SMALL MOLECULES AND/OR BIOLOGICS MEDICINAL CHEMISTRY CONSULTANT SUPPORT SERVICES

The NINDS Subject Matter Expert Consultant for Medicinal Chemistry provides technical support in the area of Medicinal Chemistry to the following programs:
• Medicinal Chemistry consulting to procure consultant services to provide technical recommendations to the NIH Blueprint Neurotherapeutics Network drug discovery and development programs.
• Help End Addiction Long-Term [HEAL] initiative. The HEAL initiative aims to optimize non-addictive therapies [small molecules and biologics] to treat pain.
• Other NIH neuroscience-focused drug discovery and development programs.

The NIH Blueprint for Neuroscience Research, a consortium of 8 NIH Institutes and Centers that support neuroscience research, established the Blueprint Neurotherapeutics Network (BPN) as a pipeline between the typical endpoint of NIH-funded research and the beginning of industry drug development. The BPN provides neuroscience researchers with funding and access to a full range of industry-style drug development services and expertise. The program is intended for projects requiring medicinal chemistry optimization and contract research organization (CRO) support through Phase I clinical testing.

Public health relevance
Subject matter expert support for projects developing therapies for neurological disorders